Photoelectrocatalytic Trifluoromethylation of Arenes via Trifluoroacetate Decarboxylation

PROJECT SUMMARY/ABSTRACT
The incorporation of C–F bonds into small-molecule therapeutics can dramatically improve their pharmacokinetic
properties, including bioavailability, lipophilicity, and metabolic stability. In accordance with the profound positive
impacts of fluorine incorporation, approximately 20% of all pharmaceuticals contain fluorine. Aryl–CF3 linkages
are a particularly common motif, present in approximately 15% of all fluorinated pharmaceuticals. Yet, a major
drawback of current catalytic trifluoromethylation methods is that commonly employed CF3 sources can be very
expensive, limiting the economic viability of trifluoromethylation reactions on large scales. Therefore, the
development of an efficient trifluoromethylation protocol employing an inexpensive CF3 source would significantly
improve the discovery and synthesis of new fluorinated pharmaceuticals.
Trifluoroacetate (TFA), which is produced annually on multi-ton scale, could serve as the desired inexpensive
CF3 source. However, the decarboxylation of TFA to generate reactive CF3 radicals (●CF3) is notoriously difficult,
due to the strongly electron-withdrawing nature of the CF3 group. Recently, the Nocera group employed a
silver(II) complex to achieve the first example of visible-light-induced TFA decarboxylation using a well-defined
metal complex. However, this method’s use of stoichiometric silver(II), as well as the incompatibility of the
reaction conditions with oxidatively sensitive substrates, limit the practicality of this advance.
The objective of this proposal is the development of a practical, catalytic trifluoromethylation method. The
stoichiometric, silver(II)-mediated method developed in the Nocera group will be modified to be catalytic in silver,
with the catalyst turned over electrochemically. This method will be applied to the production of other difficult-to-
generate radicals that are relevant to the synthesis of pharmaceuticals. Additionally, a rational ligand design
campaign will be undertaken to develop silver(II) complexes that are compatible with oxidatively sensitive
functional groups. Finally, the catalyst ligand environment will be modified to stabilize ●CF3 in the secondary
coordination sphere, allowing for catalyst control over the precise delivery of ●CF3 to substrates. The proposed
research is expected to constitute a significant synthetic advance in the field of radical trifluoromethylation.
The Nocera laboratory at Harvard University is the ideal environment to accomplish the proposed research
and training goals in preparation for a career in academia. The Nocera group will provide invaluable training in
many areas of inorganic chemistry, particularly in the development of photo- and electrochemically driven redox
reactions and in the deployment of mechanistic techniques, including transient absorption spectroscopy and
photocrystallography. Moreover, Harvard will supply numerous opportunities for skill development in scientific
education and mentoring through the Derek Bok Center for Teaching and Learning. These factors make Harvard
the optimal institution to pursue ambitious research goals and prepare for a successful future academic career.

Public health relevance
PROJECT NARRATIVE Trifluoromethyl groups are common in small-molecule therapeutics, due to the dramatic improvement in pharmacokinetic properties caused by the presence of C–F bonds. A significant limitation of established methods for the incorporation of trifluoromethyl groups into organic molecules is the high cost of many commonly employed trifluoromethylation reagents, which hinders the discovery and synthesis of new trifluoromethylated pharmaceuticals. This proposal describes the trifluoromethylation of organic compounds using a silver(II) catalyst together with inexpensive, abundant trifluoroacetate as the trifluoromethylation reagent.